Manipulating cellular excitability and CREB expression in CA1 to restore spatial processing in aged mice to young-like levels

Project Abstract
Aging is inevitable, but maybe age-related cognitive decline does not have to be. Mild cognitive impairment
and dementia are prevalent in the elderly population, and even normal aging causes subtle decline in episodic
memory, making normal cognitive aging arguably the most widespread mental health issue in the developed
world. Spatial memory is an integral component of episodic memory and is particularly impacted by aging, but
the causes behind this deficit are unknown. Without understanding the mechanisms behind age-related spatial
memory decline, society will lack the means to overcome this obstacle to healthy aging or mitigate potential
risk factors for more serious disorders such as Alzheimer's disease. This proposal will pursue two possible
factors related to spatial memory dysfunction in a mouse model of aging and its conclusions could help
translate to potential avenues of intervention in humans. Preliminary data from the Cai lab and published data
has shown that, in CA1 of the hippocampus, cellular excitability and the transcription factor cAMP response
element binding protein (CREB) are reduced in aged rodents, impacting memory function. In these
experiments, increasing CA1 excitability and CREB expression ameliorated the memory deficits of these
animals. However, these studies were unable to verify whether the underlying neural memory representations
were improved by those manipulations. The overarching goal of this proposal is determine whether increasing
CA1 cellular excitability and CREB can restore spatial memory and neural representations to young-like levels.
In the first aim, I will use designer receptors exclusively activated by designer drugs (DREADDs) to increase
excitation coming into CA1 pyramidal cells in aged mice. Simultaneously, I will perform in vivo calcium imaging
during running on different linear tracks with specific reward locations for each track to quantify the accuracy of
neural spatial representations and spatial memory. In the second aim, I will use a viral approach to
overexpress CREB in CA1 pyramidal cells of aged mice while performing calcium imaging on the same task.
The findings from these aims will allow me to conclude whether increasing CA1 excitability or CREB can
improve spatial memory representations and deficits that arise from aging. By combining chemogenetics, viral
manipulations of protein expression, and in vivo imaging, this proposal will illuminate the neural mechanisms
behind age-related spatial memory decline.

Public health relevance
Project Narrative As quality of life continues to improve in the United States, the elderly population continues to grow, and with it, the number of patients afflicted by memory deficits from normal aging. Using state-of-the-art in vivo calcium imaging, in vivo chemogenetics, and genetic manipulation of protein expression, the projects in this proposal will test possible methods of intervention for restoring young-like spatial memory function to aged rodents. These experiments will conclude whether manipulating cellular excitability or a plasticity-related protein called CREB is sufficient to restore spatial memory and coding in the aged hippocampus.